Deciphering the crosstalk between methionine metabolism and methyltransferases in health and disease

PROJECT SUMMARY/ABSTRACT
Methionine metabolism is a central regulator of protein synthesis, mitochondrial function,
antioxidant defense, and other critical cellular processes. Tightly regulating methionine flux via the
methionine metabolism pathway is essential for healthy cellular function. Not surprisingly, an imbalance
in this fundamental metabolic pathway has been attributed to numerous diseases. Yet, the molecular
link between alterations in methionine availability and dysregulation of downstream cellular processes
remains obscure. Methionine and ATP are the sole precursors for the production of the methyl donor S-
adenosylmethionine (SAM), the principal and rate-limiting methyl donor for methyltransferases (MTs),
which catalyze a variety of methylation reactions via the transfer of methyl groups onto different
substrates. Although reprogramming of methionine metabolism has been observed with different
pathological conditions, it is not known which downstream MTs link methionine metabolism to the
development of these pathological conditions and what mediates the specificity of this interaction,
representing a significant knowledge gap. I hypothesize that the identification of specific MTs will
reveal novel mechanisms by which methionine metabolism regulates essential cellular processes. The
goal of our research is to mechanistically understand how alterations in methionine are transduced into
biological effects. To accomplish this goal, my laboratory will build and sustain three research projects.
Through a preliminary screen, we identified several MTs that promote resistance to starvation or
oxidative stress similar to manipulations of the methionine metabolism pathway. I will test several
models to determine which MTs function downstream to methionine metabolism and complete the
screen of the remaining MTs (Project 1). Secondly, I will test whether the tissue-specific expression of
selected MTs help explain the specificity of how global changes in methionine levels affect specific MTs
using a novel tissue-specific methionine degradation system that we recently developed (Project 2).
Finally, we will use an open-ended proteomics approach to identify prospective downstream targets of
the identified MTs and test how these MTs affect functional responses to stress (Project 3). These
platforms interdigitate but also work independently, noting that we have already identified several MTs
that promote resistance to different stresses, so Projects 2 and 3 can be performed independently of
Project 1. We will employ innovative approaches by combining novel genetic tools that allow us to
manipulate methionine levels within specific tissues and using a state-of-the-art approach to quantify
methionine fate in vivo. The proposed research is significant because it will uncover how a central
metabolic pathway (methionine) controls many basic cellular processes. This basic research is likely to
further identify “druggable” targets relevant to multiple human pathologies associated with
reprogrammed methionine metabolism including cancer, obesity, neurodegeneration, and aging.

Public health relevance
Project Narrative The proposed research is relevant to public health because the methionine metabolism pathway is altered in a number of different diseases including cancer, obesity, neurodegeneration, and aging. By establishing a mechanistic connection between this pathway and downstream methyltransferases, we will be able to provide attractive and “druggable” targets for the development of novel therapies relevant to these diseases. Therefore, the research is relevant to NIGMS’s mission in supporting basic research that increases understanding of biological processes and laying the foundation for advances in disease treatment.